Elementary Cone Photoreceptor Representation in Primary Visual Cortex

Project Summary/Abstract
Primary visual cortex (V1) is the key cortical area in the brain that establishes how visual
perception operates in humans. Its central importance arises from two facts: V1 receives the
majority of the signals generated by the retina and it establishes the dissemination of different
types of visual information to higher cortical areas in the brain. Many previous studies have
characterized the response properties of single V1 neurons, however all of them were conducted
using the eye's natural optics, which are subject to optical aberrations. Such aberrations can
lead to confounds between wavelength, orientation, and spatial frequency in visual stimuli, in
particular at or near the fovea where these parameters are the most difficult to control. Using
adaptive optics technology, we will overcome the limits imposed by optical aberrations in order
to measure V1 neural responses at a cone-resolved level in the non-human primate for the first
time. Several fundamental questions will be answered: (1) How many cone photoreceptors
comprise a V1 neuron's receptive field near the fovea, and what cone types are they? (2) What is
the elementary response of a V1 neuron to signals provided by a single cone? (3) How many V1
neurons receive input from a single cone? In the high spatial frequency domain needed to
answer these questions near the fovea, we will be able to optically separate the parameters of
wavelength and geometric orientation in order to also address a major unanswered question
about how the visual signaling pathways in cortex are initially segregated: Do the populations of
V1 neurons that project differentially to secondary visual cortex (V2) receive input from different
cone compositions? These questions will be answered in tandem with a series of experiments
that will additionally allow us to assess the impact of cone signal loss, as a model of what occurs
in retinal degenerative diseases. By asking how resilient V1 responses may be in the face of
synthetically degraded stimuli, we will learn if there is a V1-based mechanism behind why
perceptual deficits in patients are often not as severe as retinal imaging of diseased tissue
indicates. Our results will establish the basic signaling properties of cone photoreceptors as
seen by V1 neurons and potentially reveal a cortical signature for perceptual “filling-in” at the
single neuron level. Both of these outcomes will substantially improve our understanding of
visual processing and create a new path for earlier detection of retinal disease.
1

Public health relevance
Project Narrative How the activity of individual cone photoreceptors drive neurons in primary visual cortex is unknown, yet it is the basis of visual perception. Using adaptive optics technology to visualize and stimulate single cones in vivo, we will characterize the elementary responses of single primary visual cortical neurons in non-human primates, using normal and synthetically degraded visual stimuli. Our results will help us to understand how cortical neuron responses are built from the small array of cone photoreceptors that provide input and reveal the cortical mechanism behind the perceptual resilience that occurs during retinal disease progression. 1